ACTG 300--STUDY OF 3TC, ZDV AND DDI IN HIV INFECTED CHILDREN

This Phase II/III, randomized, comparative, double-blind, 3-arm, outpatient, multicenter study is designed to compare effectiveness of 3TC/ZDV versus the better of ddI monotherapy versus ZDV/ddI combination therapy with respect to HIV disease progression. The safety and tolerance of 3TC/ZDV in ZDV naive, symptomatic children with HIV-1 infection will be evaluated.